Neurovascular Control of Renal Blood Flow During Exercise in African American Adults

Project Summary
African American (AA) adults have a greater risk for developing cardiovascular and renal disease (CVRD) than
White (W) adults. Elevated sympathetic nervous system activity, usually occurring in response to stressors, is
associated with increased incidence of CVRD. Physical exertion, such as exercise, acutely increases
sympathetic nervous system activity directed towards the kidneys, resulting in renal vasoconstriction and
reduced renal blood flow (RBF). Limited research shows that healthy young AA adults exhibit exaggerated
sympathetic responsiveness both at rest and during sympathetic activation, which may be a major contributor to
the increased risk of CVRD in this population. However, the acute renal vasoconstrictor response to any
sympathetic nervous system activation has not been investigated to date in AA adults. During sympathetic
nervous system activation such as exercise, sympathetic neural activity directed to the kidneys and/or the
resultant vascular response might be exaggerated in AA adults, contributing to greater renal vasoconstriction
and a larger reduction in RBF. Over time, this exaggerated neurovascular response to sympathetic activation
could have a negative cumulative effect on the kidneys, which could be a contributing factor to the greater
incidence of CVRD in this population. Therefore, this proposal aims to examine the renal vasoconstrictor
response to sympathetic stressors in healthy AA adults prior to development of CVRD, which will be achieved
via two specific aims. Our first aim is to determine the renal vasoconstrictor response to acute dynamic exercise
in healthy young AA adults compared to healthy young W adults. Specifically, we will use state-of-the-art
methods to measure RBF velocity and BP at rest and during acute cycling exercise to calculate renal vascular
resistance responses to exercise. We will test the hypothesis that healthy young AA adults exhibit an
exaggerated renal vasoconstrictor response to acute cycling exercise compared to healthy young W adults. In
our second aim, we will assess the renal vasoconstrictor response to non-exercise sympathetic stressors in
healthy young AA adults compared to healthy young W adults. Specifically, we will measure RBF velocity and
BP at rest and during cold pressor and mental stress tests to calculate renal vascular resistance responses to
these non-exercise stressors to test the hypothesis that healthy young AA adults exhibit exaggerated renal
vasoconstrictor responses to non-exercise sympathetic stressors compared to healthy young W adults. We will
use the highly innovative approach of Doppler ultrasound to measure RBF during exercise and non-exercise
sympathetic stressors non-invasively and with high temporal resolution to complete these specific aims. This
novel approach by our experienced research team to assess the renal vasoconstrictor response to sympathetic
stressors in AA adults will provide new, mechanistic insights in this understudied yet clinically significant area.
The findings from this project will advance our understanding of why AA adults have elevated CVRD risk, with
implications for future efforts toward prevention of CVRD.

Public health relevance
Project Narrative African American (AA) adults experience an increased risk for developing cardiovascular and kidney diseases, including high blood pressure, compared to White (W) adults. This project will examine whether healthy young AA adults have a greater physical response to stressors such as exercise than W adults, and whether this response leads to less blood flow to the kidneys during exercise and other stressors. The impact of the knowledge gained in this understudied yet clinically significant area will advance our understanding of the possible mechanisms underlying the elevated cardiovascular and kidney disease risk in AA adults.